Commensal control of C. difficile virulence

Abstract: Clostridioides difficile, the etiology of pseudomembranous colitis, causes substantive
morbidity, mortality and close to $5 billion/year in US healthcare costs. Commensals provide
primary protection against C. difficile infections though the underlying mechanisms of action
remain ill-defined. We have identified individual bacterial species that provide long-term survival
against virulent C. difficile strains, and other species that can make the infection worse. Our
proposed aims will define specific commensal activities and commensal genes mediating these
effects on the pathogen, and test their functions in vivo, in mice carrying mouse vs human complex
microbiota, for the purposes of developing defined bacteriotherapeutics and biomarkers to predict
successful therapy.

Public health relevance
Narrative Clostridioides difficile causes severe infections of the colon, infections that commonly arise after use of antibiotics that destroy healthy populations of microbes which prevent infection. Our proposed studies are defining the specific microbes that provide this protection, and their mechanisms of action. This knowledge will be used to help create more defined, effective and safe therapies for this disease.